ONTOGENETIC DEVELOPMENT OF MEMORY AND HABIT FORMATION

Cognitive memory and habit formation are two qualitatively different learning processes based on separate neural systems, a cortico-limbic and a cortico-nonlimbic system, respectively. To see how emotional and social behavior develop in animals whose infantile global amnesia might persist from infancy through adulthood, we have prepared monkeys with neonatal limbic lesions and followed their behavioral development. Animals with neonatal removal of cortical area TE, a higher-order visual station linked to both learning systems, serve as controls. The results indicate that neonatal TE lesions leads to a transient impairment of habit formation three months later (compared to permanent impairment seen with the same lesion in adults), whereas both neonatal and adult limbic lesions leave habit formation intact. Interestingly, data on both normal and operated infants suggest that development of the nonlimbic habit system is sexually dimorphic, and that this is due to the high testosterone levels present in male infants before and shortly after birth. At ten months of age, the infants with limbic lesions show impairment in memory formation, whereas the operated controls show significant functional sparing (compared to those that received the same lesions as adults). These findings point to greater compensatory potential after neonatal cortical than after neonatal limbic removals, indicating that association areas of the cortex are immature at birth, and may thus possess greater plasticity than limbic structures. Direct evidence of neocortical immaturity in the macaque has been provided by our neurobiological studies on opiatergic and cholinergic receptor distribution and on metabolic activity. Finally, early damage to the limbic memory system produces later socio-emotional abnormalities that are similar in many respects to the behavioral syndrome seen in autistic children.